Interdisciplinary protein engineering approach to design high affinity antibodies for flaviviruses

Abstract
Recombinant monoclonal antibodies considered a new modality of therapeutic treatment to fight viral
infections. A particular challenge for viral mAb development is the isolation and characterization of mAbs with
broadly neutralizing activity (bNAbs) against multiple members of a single viral family to provide an
immunotherapeutic advantage, particularly for infectious agents whose cases can progress rapidly toward
serious disease.
Our goal for the identification of bNAbs is protein engineering by a synergistic combination of
computational and experimental methods, to enhance the breadth and potency of a specific mAb using
designed mutations. Phage display provides an efficient way to randomly explore up to 1010 unique library
members simultaneously. However, a typical antibody-antigen interface of ~15 residues present a
combinatorial possibility of 2015 mutational variants, only a fraction of which can be sampled. As a result, phage
display and other antibody combinatorial methods are reliant on restriction of either amino acid diversity or
interfacial positions, which limits the effectiveness of the approach. To circumvent this limitation, we propose to
develop an interdisciplinary approach where computationally designed, residue-based pharmacophore
descriptions of the antibody-antigen interface are used to direct the library design in subsequent phage display
experiments. As a test bed for this method, we will engineer novel bNAbs against flaviviruses, which include
the globally important pathogens dengue virus and Zika virus.

Public health relevance
Project Narrative Engineered antibodies present a new treatment modality for viruses to circumvent major obstacles presented by the existence of various serotypes in certain viruses, and to address the development of engineered antibodies that can cross-react related viruses. These two applications are the focus of this interdisciplinary proposal, where a computational residue-based pharmacophore description of the monoclonal antibody interface is used to direct phage display experiments in order to identify broadly neutralizing or cross-reacting antibodies against dengue and Zika viruses.